MEMBRANE FUNCTION DURING GERMINATION OF CANDIDA ALBICANS

The effect of perturbing membrane biogenesis on yeast cell germination and chitin biosynthesis will be studied in Candida albicans. Our approach in investigating these issues will be to dissect the steps leading to germination by employing agents tht inhibit the process. In particular, we will utilize the antilipogenic agent, cerulenin, to manipulate the phospholipid and sterol composition of membrane-containing structures, and then determine the effect of such changes on morphogenesis. Sodium butyrate, an agent that does not directly influence lipid biosynthesis, will be employed as an alternative inhibitor of Candida albicans germination, so that we may distinguish between events inhibited by cerulenin that are correlates of morphogenesis from those events only coupled to inhibition of lipid biosynthesis. In addition, several cerulenin-resistant C. albicans mutant strains have been isolated. These strains will be exploited directly, and will also be utilized as experimental controls, where appropriate. Preliminary experiments have shown that both cerulenin and butyrate effectively block germination and inhibit chitin synthase activity in C. albicans at concentrations that do not significantly affect yeast cell growth or protein synthesis. We will now extend these studies utilizing biochemical and molecular techniques to: 1) Examine the relationship between membrane structure, chitin synthase regulation and activity, and germination. 2) Determine the influence of the membrane phospholipid/sterol composition on membrane and cell wall proteins, as well as on cell surface components. 3) Examine factors that may influence adherence properties of Candida. 4) Assess the contribution of mitochondria to Candida germination. These investigations will provide insight concerning both dimorphism and pathogenesis of C. albicans.